Softward to facilitate adoption of the Sequence Ontology for genome management

[unreadable] DESCRIPTION (provided by applicant): Genome annotations combine sequence, the results of bioinformatics analyses, and the knowledge of human curators into models of gene structure. These annotations provide a basic resource for investigations into the genetic causes of human disease. Despite their potential as a resource for such studies, genome annotations have proven difficult to use. A major reason for this has been the lack of community standards for describing them, which has resulted in the proliferation of arbitrary file formats and database schemas. In order to solve this problem, the Gene Ontology Consortium has developed the Sequence Ontology (SO). The purpose of SO is unify the description of genome annotations. Many model organism databases such as SGD, WormBase and FlyBase have now adopted SO, and release their annotations in SO-compliant formats. Many other genome databases are attempting to follow suite, but are finding it difficult to do so. One reason for their difficulties is the lack of publicly available software for managing and distributing SO- compliant genome annotations. The goal of this proposal is to further develop, improve and consolidate existing software tools that will help the broader genomics community to use the Sequence Ontology as a tool to produce, manage, and disseminate SO-compliant genome annotations. Our proposed data adapters and converters will help bring old annotation data and software forward; our SO-based quality control pipelines will ensure that the data produced by different databases is indeed interoperable; and our navigation and database search tools will help human curators to produce higher quality SO-compliant genome annotations. [unreadable] [unreadable] [unreadable]